Genomics and Computational Biology Shared Resource

GENOMICS AND COMPUTATIONAL BIOLOGY SHARED RESOURCE ABSTRACT
The Genomics and Computational Biology Shared Resource (GCBSR) is directed by KA Frazer, an
established and highly productive investigator, who has broad expertise in the field of genomics, and co-
directed by P Tamayo, a well-funded experienced computational biologist and cancer genomics researcher.
Together, they oversee a confederation of 2 units that make up the GCBSR: Institute for Genomic Medicine
Genomics Center (IGM Genomics Center), operationally directed by Kristen Jepsen, and the Center for
Computational Biology and Bioinformatics (CCBB), operationally directed by Kathleen Fisch. The GCBSR
consists of an integrated team of highly qualified scientists, engineers and technicians with the requisite
expertise in study design, data generation, data analysis and interpretation to enable Moores Cancer Center
(MCC) investigators to execute high-throughput genomics projects. The major objectives of the GCBSR are
to provide MCC investigators with high quality, cutting edge genomic profiling and data analysis services, as
well as with consultation on experimental design and training/education. This will enable MCC researchers to
conduct innovative research on high priority projects central to the goals of the MCC strategic plan and the
Research Programs. The overarching goals of the GCBSR are to: 1) Provide expert consultation to MCC
membership on experimental designs and analysis approaches of large-scale genomics datasets; 2) Generate
high-throughput sequence data in a cost-effective manner and offer this as a service for the MCC membership;
3) Perform primary analysis and interpretation of high-throughput sequence data including, DNA variant calling,
mRNA isoform calling, miRNA analysis and DNA methylation analysis; and 4) Perform advanced integrative
data analysis including, tumor profiling for DNA somatic mutations, differential expression analysis, gene
enrichment analysis, network and systems analysis. Previously rated Outstanding, several improvements were
made during the project period to ensure that the GCBSR continues to keep pace with current technologies
and continues to provide the highest quality cost-effective services to MCC members. The GCBSR acquired
several cutting-edge pieces of equipment that have increased throughput, lowered prices, and provided newly
available technologies to MCC users. Furthermore, GCBSR created a bioinformatics and computational
biology resource to support the analysis of large molecular datasets, with special emphasis in the areas of
genomics, transcriptomics, systems biology, cancer genomics and translational medicine.